Targeted closed-loop intracranial brain-stimulation to improve episodic memory

Project Summary
This project aims to determine how invasive closed-loop electrical stimulation can potentially rescue patterns of neural activity in the brain that give rise to successful memory
functions. With an eye towards helping people affected by disorders of memory – including the ever-growing population suffering from neurodegenerative diseases, such as
Alzheimer's – we propose to assess how functional brain dynamics can be used to guide
the optimal timing, location, and properties of direct brain stimulation. Prior work has
identified specific patterns of neural activity across the brain, principally spectral modulations in the theta (3-8 Hz) and gamma (30+ Hz) bands, that predict successful memory
encoding and retrieval. We recently observed that the effect of stimulation on memory
encoding depends on these neural signatures at the time it is delivered. Furthermore,
we have shown that the functional and structural connectivity profile of a stimulation
site relates to the effectiveness of stimulation on memory. Here, we aim to elucidate (1)
whether state-dependent stimulation can separately be used to modulate encoding and
retrieval processes, or whether common stimulation algorithms applied to both phases
can more optimally restore function, (2) whether stimulation is more effective when targeted to regions with specific connectivity profiles to the medial temporal lobe, and (3)
how simultaneous stimulation at multiple target sites can be optimized with knowledge
of the connectivities of those sites. More broadly, this project seeks to determine whether
biomarker-guided, closed-loop brain stimulation can be used to correct pathologic brain
states and restore the function of an impaired memory system.

Public health relevance
Project Narrative Diseases that affect human memory are among the most prevalent and devastating in modern society, including Alzheimer's disease, stroke, and traumatic brain injury. However, the neural activity that supports memory – and the ways in which it fails – remain poorly understood. Worse yet is our understanding of how to adaptively intervene to correct disordered brain dynamics. This project will facilitate the discovery of electrophysiological biomarkers that indicate risk for cognitive loss in neurologic disease, and will guide the development of neurotherapeutics that repair altered brain states via closed-loop targeted intracranial stimulation.